Virulence Determinants of Borrelia burgdorferi

DESCRIPTION (provided by applicant): Borrelia burgdorferi is the causative agent of Lyme disease in North America and is transmitted by ticks of the genus Ixodes. It is a highly invasive spirochete that can cause infection and manifestations in humans and other mammals that persist for months to years. The infection has localized, disseminated, and persistent phases, and B. burgdorferi appears to cause dermal, neurologic, cardiovascular, and arthritic symptoms primarily though the ability to invade almost any tissue, establish long-term infection, and induce inflammatory responses. The bacterium produces no known toxins, and its mechanisms of pathogenesis are largely unknown. Genetic studies using low-passage, infectious B. burgdorferi have been challenging due to exceedingly low transformation rates and plasmid loss; as a result, fewer than 50 genes have been investigated by allelic exchange or other site-directed mutagenesis methods for their importance in the mammal-tick infectious cycle. During the prior grant period, a sequence-defined library of 4,479 signature- tagged mutagenesis (STM) transposon mutants was generated in a transformable, infectious clone of B. burgdorferi B31. The plasmid content of the clones in this library was also determined using a novel Luminex-based high throughput strategy. Using the library, we have already performed STM screening of mouse infectivity of 484 transposon mutant clones in 434 different genes. In Aim 1, the roles of the 1740 protein-encoding genes in the infection of C3H/HeN mice will be analyzed systematically using the STM mutant library. For this analysis, we will employ the Luminex-based STM protocol developed during the prior grant period (Luminex-STM) to analyze each clone in 3 mice, 5 different tissues, and two time points in a high throughput manner. The goal of Aim 2 is to determine the effects of the transposon mutations on infectivity, persistence and transmission of B. burgdorferi in Ixodes scapularis ticks. Groups of the STM mutants obtained in Aim 1 will be inoculated into mice by immersion of larval ticks into a mixture of organisms with different mutations and signature tags. The survival of the STM clones will be analyzed before and after feeding on mice, and transmission of the clones to the mice will also be determined by Luminex-STM. In Aim 3, the findings in Aims 1 and 2 will be used to select classes of mutants for detailed infectivity, complementation, and functional analysis. We anticipate that these analyses will include studies of genes involved in chemotaxis, motility, nutrient transport, surface proteins involved in adherence and other roles, novel gene regulation pathways, and additional gene sets identified during the STM screening procedure. The STM library will also be made available to any interested investigator through BEI-Resources, providing maximal resource sharing and stimulation of Borrelia research. We anticipate that this project will continue to fuel new discoveries useful in improving the diagnosis, treatment, and prevention of Lyme borreliosis.

Public health relevance
Lyme disease, the most common arthropod-borne disease in the United States, is caused by the spiral-shaped bacterium Borrelia burgdorferi and related organisms. These bacteria are transmitted by ticks and cause a long-term infection in people that affects the skin, nervous system, joints, and heart. Because we know so little about how B. burgdorferi causes disease, it is difficult to design better ways to prevent, diagnose, and treat Lyme disease. The goal of this study is to identify every B. burgdorferi gene that is important in the infection process, so that we can use the resulting information to help reduce the impact of Lyme disease on people in the United States and in other parts of the world.